STRUCT GROEL COMPLEXED W/ NON HYDROLYZABLE ANALOG OF ATP: ANGSTROM RESOLUTION

We have determined the structure of unliganded GroEL by x-ray crystallographyto 2.8 angstroms resolution (Brain/Otwinowski, et al., Nature, in press). Initial crystallographic refinement of the model using XPLOR (Brunger, XPLOR version 3.1 Manual, 1993) has resulted in a structure that has an overall R-factor of 32/%. The limited resolution has made further refinement difficult. However, we have also solved the structure of a different crystal form of GroEl, complexed with a non-hydrolyzable analog of ATP, to beyond 2.5 angstroms resolution. This level of resolution will allow for simulated annealing, part of the standard refinement protocol in XPLOR, which should facilitate the crystallographic refinement of GroEl. Because this crystal for contains 66,326 atoms in the asymmetric unit and 602,895 reflections, we are constrained by the limitations of our computers here at Yale. Therefore, we believe that we can greatly benefit from the resources at the Pittsburgh Supercomputing Center.